UTAH PELVIC FLOOR DISORDERS NETWORK

[unreadable] DESCRIPTION (provided by applicant): Pelvic floor disorders are common, bothersome, and inadequately treated. The overarching aim of the investigators from the proposed University of Utah Pelvic Floor Disorders Clinical Site is to improve women's health in the area of pelvic floor dysfunction. To this end, site specific aims include: 1) Identifying priority areas of research, 2) Developing assessment tools, 3) Developing and implementing PFDN protocols, 4) Recruiting and enrolling subjects in PFDN protocols, 5) Achieving on-target recruitment goals and high subject retention, 6) Ensuring high-quality data, 7) Transmitting data accurately to the Data Coordinating Center, 8) Participating in data analysis, 9) Disseminating results to the research community, and 10) Producing high-quality publications. The broad scientific aim for the randomized clinical trial outlined in this proposal is to evaluate whether post- operative pelvic floor muscle training following surgery for pelvic organ prolapse and/or stress urinary incontinence improves post-operative outcomes (anatomic, symptomatic and quality of life outcomes) at 3 months, 1 year and 2 years post-operatively. [unreadable] [unreadable] [unreadable] [unreadable]